Epigenetic Regulation of Orofacial Bone Homeostasis and Aging by KDM4B

Project Summary/Abstract
The goals of this application are to understand the epigenetic and molecular mechanisms that control
orofacial bone aging and osteoporosis in parallel with long bones and explore the extent to which targeting
epigenetic factor could prevent orofacial bone aging and promote dental, oral and craniofacial tissue
regeneration. Aging causes significant changes to bone, characterized by a decrease in the adult stem cell
pool, self-renewal and trabecular bone formation, and an increase in marrow adipose tissue accumulation.
Orofacial bone, especially alveolar/trabecular bone, is a dynamic and self-renewing tissue with high turnover
rate which often dramatically decreases with aging. Mesenchymal stem/stromal cells (MSCs) are adult stem
cells in long and orofacial bones and are responsible for continuous tissue renewal, regeneration, and repair.
MSCs derived from orofacial bone tissues (OMSCs) are excellent sources for craniofacial bone regeneration
due to their closer embryonic origins to the injured sites. Over the past decade, significant progress has been
made in understanding the molecular mechanisms governing skeletal aging and osteoporosis. However, little
is known about how epigenetic factors control skeletal homeostasis and aging, specifically orofacial bone
aging. Using siRNA screening, we discovered that the histone demethylase KDM4B played a critical role in
osteogenic differentiation of BMSCs by erasing trimethylated histone H3 at lysine 9 (H3K9me3). The
expression of Kdm4b was significantly downregulated in BMSCs isolated from aging mice compared to
young mice. To explore the functional role of KDM4B in orofacial bone homeostasis and aging, we utilized
Prx1Cre mice to delete Kdm4b in limb and cranial mesenchyme. We found that the deletion of KDM4B
accelerated orofacial bone aging and osteoporosis by reducing bone formation and increasing adipogenesis.
Importantly, we also identified that parathyroid hormone (PTH), which has been showed to regulate MSC
stemness and fate decision, induced Kdm4b in OMSCs. Based on these exciting studies, we hypothesize
that KDM4B is a critical epigenetic factor which controls orofacial bone aging and OMSC stemness, and
induction of KDM4B promotes OMSC-mediated craniofacial bone regeneration. To test our hypothesis, we
propose the following three specific aims: 1) To determine whether KDM4B plays a critical role in regulation
of fate decision, osteogenesis and self-renewal of OMSCs in parallel with BMSCs; 2) To determine whether
induction of KDM4B prevents orofacial bone aging and promotes orofacial bone regeneration in vivo in
parallel with long bones; and 3) To explore epigenetic mechanisms by which KDM4B controls orofacial bone
aging and self-renewal of OMSCs in parallel with BMSCs. New findings from our studies will have important
implications in developing innovative therapeutic strategies for preventing orofacial bone aging and
promoting craniofacial bone regeneration.

Public health relevance
Public Health Relevance Statement Our application is to examine how the epigenetic factors regulate self-renewal and fate decision of orofacial adult stem cell and orofacial bone aging and explore whether targeting the epigenetic factors could counteract orofacial bone aging. The discoveries from this study will have important implications in developing novel strategies for preventing aging-related orofacial bone loss and promoting stem cell-mediated craniofacial bone regeneration.